Epigenetic Therapy of Periimplantitis

Over the recent sixty years, dental titanium implants have been almost universally
accepted as a leading and safe system to replace lost and diseased teeth, largely due to the
biological qualities of titanium to be seemingly inert to the body’s immune system. Yet, the
increased longevity of patients with implants, the increased lifespan of implants within individual
patients and the increased number of elderly patients with implants have exposed the number of
implant failures as an everyday reality in clinical dentistry. Potential etiologic factors that
contribute to peri-implantitis include oral plaque accumulation; titanium particle/ions released
from dental implants, complications from implant surgery, and others. In our preliminary
studies, we have successfully established a rat peri-implantitis model using immediate titanium
implants in a rat mandible. We have used this model in our quest for potential mechanisms that
explain peri-implantitis, including inflammation of the peri-implant environment, loss of bone and
a dramatic increase in reactive oxygen species (ROS). Further studies uncovered an epigenetic
mechanism through the SETD7-SFRP1-Runx2 pathway explaining titanium particle induced
changes in implant bone homeostasis. Specifically, we demonstrated that both the
methyltransferase Setd7 and the Wnt-inhibitor SFRP1 were upregulated in titanium-challenged
PDL cells while both enrichment for H3K4me1 and Setd7 on the promoter of the SFRP1 Wnt
inhibitor were increased. Together, these studies are geared to test the hypothesis that
periimplantitis progresses as the result of an inflammatory microenvironment and oxidative
stress and that this trend may be reversed through the application of epigenetic modulators.

Public health relevance
Over the recent sixty years, dental titanium implants are a largely successful means for the restoration of lost teeth. Occasionally they become inflamed resulting in a loss of these implants. Here we have designed studies to curb this inflammation and reverse the loss of implants, leading to a restoration of the dentition.